Modulation of BRD4 to epigenetically suppress HIV

ABSTRACT
Integration of HIV viral DNA into host cell genomes and establishment of stable latent infection have posed a
major obstacle for finding an HIV cure. HIV proviral expression in cell reservoirs is regulated by host epigenetic
and transcriptional mechanisms. Identification of effective approaches targeting host machineries to disrupt or
enforce HIV latency is a significant goal. BRD4 is an epigenetic reader that belongs to the bromodomain (BD)
and extra-terminal domain (ET) protein family (BET). Via the BDs, BRD4 binds to acetyl-lysine (KAc) residues
in chromatin histones and serves as a scaffolding platform for recruiting partner proteins through protein-protein
interactions (PPI) to regulate gene transcription, including HIV. Modulation of BET/BRD4 by a pan-BET inhibitor
(JQ1), which targets the classic KAc binding site in BDs, has been shown to activate HIV transcription. Recent
studies by my group and others indicate that BRD4 is functionally versatile, and its activity on gene transcription
is tailored by specific partner proteins it engages. Using structure-aided design, our studies (1, 2) have identified
a lead small molecule (ZL0580) and several analogs that are distinct from JQ1 but induce HIV transcriptional
suppression through BRD4. We demonstrate that ZL0580 induces suppression of both transcriptionally active
and latent HIV in multiple cell models, including J-Lat, CD4 T cells and myeloid cells/microglia. Docking analyses
of binding modes and mechanistic investigations indicate that unlike JQ1, ZL0580 targets a distinct new region
of BRD4 BD1 for binding [non-acetyl-lysine (KAc) site] and induces HIV transcriptional suppression by inhibiting
Tat transactivation and by inducing a repressive chromatin structure at the HIV LTR. Based on these novel
findings, our central hypothesis is that host BRD4 and its associated epigenetic machinery can be modulated
to repress HIV, leading to enforced HIV latency. Other than ZL0580, our ongoing research has identified another
analog (YL0255) that is structurally close to ZL0580 and induces stronger HIV suppression. In this application,
we will use ZL0580 and YL0255 as two novel molecular probes to systemically investigate modulation of BRD4
in HIV epigenetic suppression. In Aim 1, we will determine if BRD4 is a selective protein target for
ZL0580/YL0255 and the underlying structural basis. In Aim 2, we will elucidate the molecular mechanisms by
which modulation of BRD4 by ZL0580/YL0255 induces HIV epigenetic suppression. In Aim 3, as a proof of
concept, we will examine if modulation of BRD4 by ZL0580/YL0255 induces repression of latent HIV in vivo.
Collectively, these studies are critical for better understanding HIV epigenetic regulation and latency and will lay
critical groundwork for developing novel strategies for inducing HIV suppression and/or silencing in future.

Public health relevance
Narrative HIV continues to cause a global pandemic with more than 36 million infections worldwide. In this project, we aim to understand the molecular mechanisms for the modulation of BRD4 to induce HIV epigenetic suppression and to test as a proof of concept if the two novel small molecules identified in our laboratory can induce repression and/or silencing of latent HIV in vivo by modulating this pathway.